Systems Biology of Early Atopy (SUNBEAM) Analysis and Bioinformatics Center

PROJECT SUMMARY
Food allergy (FA) and atopic dermatitis (AD) are common chronic conditions of atopy affecting 10% and 20%
of children, respectively. Individuals with FA are at daily risk for potentially life-threatening hives, angioedema,
respiratory difficulty, cardiovascular compromise, gastrointestinal distress, and/or anaphylaxis following
ingestion of a food antigen to which they are sensitized. Individuals with AD must live with chronically pruritic,
inflamed skin that can cover a significant proportion of their bodies and become infected. The development of
FA is frequently preceded by AD, suggesting shared risk factors and overlapping pathobiology. FA and AD are
complex diseases, and parsing the biological heterogeneity hidden under their clinical umbrellas is paramount
to improving their prevention, diagnosis, and clinical management. A systems biology approach where the
biology of FA and AD are investigated comprehensively at several levels may help identify new knowledge
about the development of allergy. Systems Biology of Early Atopy (SunBEAm) is a general population pre-birth
cohort study initiated by the NIAID to study the role and inter-relationships of genetic, clinical, biological, and
environmental early-life factors in the development of allergic diseases, with an emphasis on FA and AD.
Pregnant women, children born to them, and the children's biological fathers are being enrolled and
phenotyped with longitudinal biosample collections. A central goal of SunBEAm is to apply systems biology to
identify mechanisms and biomarkers underlying the development of FA, AD, and their endotypes. The
overarching goal of this SunBEAm Analysis & Bioinformatics Center (ABC) application is to create a
center for assaying SunBEAm biosamples using omics, and to apply integrative systems biology to
identify novel determinants of FA and AD. Our application centers on these five specific aims: (1) Assay
biosamples from SunBEAm participants to generate longitudinal, multi-scale omic data that will inform on the
development of FA and AD; (2) Analyze the systems-wide omic data generated to identify novel biomarkers,
endotypes, and mechanisms underlying the development of FA and AD; (3) Integrate data across molecular
dimensions to identify key drivers and predictors of FA and AD development; (4) Share all generated data,
create a centralized platform for SunBEAm data and bioinformatic innovations, and build capacity for the
integration of future SunBEAm omics data; and (5) Develop infrastructure for interactions with the SunBEAm
Steering Group, the NIAID Statistical and Clinical Coordinating Center, and NIAID. With this award, we will
create a center for unprecedented systems allergy research. In addition to an investigator team with world-
class expertise in multi-omics, systems biology, computational biology, data science, and bioinformatics, our
team also includes physician-scientists and immunologists who directly designed and continue to actively drive
the ongoing enrollment and implementation of SunBEAm. Our team's experience, expertise, and proven track
record will ensure the success of SunBEAm-ABC.

Public health relevance
PROJECT NARRATIVE Food allergy and atopic dermatitis are common allergic conditions affecting 10% and 20% of children, respectively. Systems Biology of Early Atopy (SunBEAm) is a general population pre-birth cohort study initiated by the NIH to study the role and inter-relationships of genetic, clinical, biological, and environmental early-life factors in the development of allergic diseases, with an emphasis on FA and AD. The SunBEAm Analysis & Bioinformatics Center will assay SunBEAm biosamples using high dimensional profiling and apply integrative systems biology to identify novel determinants of FA and AD.